Biomedical Imaging for Clinician Scientists

Project Summary/Abstract
This is the fourth renewal application of a structured intensive one-year training program in Biomedical Imaging
research based in the Department of Radiology and Biomedical Imaging at UCSF. The program is motivated by
an increasing shortage of clinician scientists who are critically needed to develop and translate innovative
imaging technologies to optimally diagnose and treat diseases. Over the last 17 years the “Biomedical Imaging
for Clinician Scientists (BICS)” program at UCSF has been highly successful in training leaders in Academic
Radiology, with the current department chair being one of the first group of T32 trainees. It should also be noted
that 77% of the T32 trainees are now faculty at academic institutions throughout the US, while only 18.5% of
UCSF radiology residents who did not complete the T32 training are at academic institutions. The T32 program
will be open to clinician scientists at the resident and fellow level interested in biomedical imaging research. The
primary long-term objective of this program is to train clinician scientists who will become leaders in Biomedical
Imaging. To achieve this, candidates with demonstrated potential in biomedical imaging research will be recruited
and mentored by a designated team of experienced researchers including clinician and basic scientists. Each
trainee will be affiliated with one of the existing research groups and clinical sections within the Department of
Radiology, and collaborate with researchers from both within and outside of the department in multidisciplinary
high impact research projects spanning the spectrum of biomedical imaging ranging from molecular imaging to
artificial intelligence. All T32 trainees will also undertake formal course training in research design and statistical
methods including scientific rigor and responsible conduct of research, as well as grant writing. The T32 program
integrates rigorous research training with robust mentorship to support the trainees in career development. Each
trainee is paired with a project specific research mentor as well as a career development mentor who together
help the trainee develop a career path for success in academic radiology. Given its unique resources, UCSF
Department of Radiology is ideally positioned to provide such a training program, supported by the large research
program and the high number of established researchers within the Department. The depth and diversity of the
clinical and research work within the Department of Radiology provides an optimal environment for the T32
trainees. The T32 trainees will be based within the new Life Sciences Mission Bay and China Basin campuses
of UCSF, which offer unique resources for collaborative research. These new resources will further increase the
ability of the Department to attract researchers and continue the long tradition of ground breaking, cutting edge
Biomedical Imaging Research. This training grant will not only strengthen biomedical imaging research at UCSF
but also increase the number of highly trained and qualified clinician scientists across the US.

Public health relevance
Project Narrative There is a critical shortage of Academic Radiologists who are rigorously trained in Biomedical Imaging Research. These highly skilled and trained individuals are crucial to advance research in imaging and image-guided therapies, which will directly impact patient care. This new generation of Academic Radiologists will be essential to maximize the healthcare benefits that will come from interdisciplinary translational research linking advances in the sciences of genomics, proteomics and artificial intelligence with the ongoing technological evolution in Biomedical Imaging